Evaluating clinician communication around glycemic management and its health impact for people with diabetes

PROJECT SUMMARY / ABSTRACT
The objective of this project is to conduct a mixed methods study characterizing clinician communication
around glycemic management (glycemic treatment and glycemic goals), identifying and quantifying the most
effective communication practices. A large proportion of people with diabetes in the U.S. do not achieve glycemic
goals, and suffer worse outcomes and likely more stigmatizing and judgmental language in clinical settings.
While there is strong evidence that high quality clinician communication (defined as informative, compassionate,
motivating and free of stigmatizing and judgmental language) improves diabetes outcomes, no studies to date
have directly observed diabetes communication within clinical visits, and there are no validated tools for
measuring the quality of this dialogue. Therefore, the specific communication practices that are most helpful (or
harmful) for people with diabetes are not known, creating a major barrier to developing and implementing
interventions that harness the power of clinical communication to improve diabetes care. Further, existing
evidence-based communication interventions are high intensity and difficult to disseminate, creating a need for
pragmatic interventions achievable within primary care practice. We hypothesize that changing clinician
communication practices in simple, pragmatic ways is likely to improve diabetes self-management, which should
in turn lead to improved glycemia and lower complications.
In Aim 1, we will characterize clinician communication around glycemic management in 121 primary care
visits for people with diabetes and HbA1c ≥8.0%. We will utilize data from the Black Box of Cultural Competence
(Black Box) study, an observational cohort that audio-recorded routine primary care visits between people with
diabetes and their primary care provider in the Veterans Affairs health system. We will use qualitative content
analysis to identify features of good and poor communication quality, and use conversation analysis (a method
of parsing the linguistic details of interactions) to evaluate the responses of people with diabetes, identifying the
specific communication approaches and language that have the strongest positive and negative impact. In Aim
2, we will develop and psychometrically validate an instrument to quantitatively rate clinician communication
quality around glycemic management, and determine its association with diabetes self-management abilities.
These aims lead directly to our next steps: developing primary care interventions to improve diabetes
outcomes. Identifying the most effective communication strategies will lead to efficient interventions that optimize
clinicians’ language through targeted changes, and increase the ability of the healthcare team to support people
with diabetes. Further, a validated instrument to measure the quality of glycemia management communication
can serve as an important surrogate outcome for clinical interventions. Ultimately, we will leverage the power of
clinical communication to improve outcomes for people with diabetes.

Public health relevance
PROJECT NARRATIVE There are 38 million adults in the U.S. who have diabetes, and two in five do not achieve the recommend goals for their blood sugar. While there is strong evidence that high quality clinician communication (defined as informative, compassionate, motivating and free of stigmatizing and judgmental language) improves diabetes outcomes, studies have not identified the specific communication practices that are most effective. This proposal will fund studies to characterize communication around diabetes treatment and blood sugar, to understand the specific communication practices that are most helpful (or harmful) for people with diabetes.